Special Projects Sample Collection

Missouri Department of Health and Senior Services State Public Health Laboratory Project Abstract for FOA PAR-20-105 Laboratory Flexible Funding Model Discipline D (Special projects): Track 1 Sample Collection Purpose: The Missouri Department of Health and Senior Services (DHSS) State Public Health Laboratory (MSPHL) seeks FDA cooperative agreement funding opportunity to assist in obtaining surveillance program food samples. The funds provided by the grant will be utilized to compensate the Missouri’s manufactured food regulatory programs (MFRPS) for collection of the samples. The goals and outcomes of this cooperative agreement include the following: 1. The MSPHL will enter into an agreement with Missouri’s MFRPS program to collect more than 1,000 targeted food samples suggested by the FDA. 2. Missouri’s MFRPS program will collect the agreed upon samples. Page 1 of 1